Interrogating the role of IFNgamma in promoting metastasis and immune evasion of triple negative breast cancer

Project Summary
During metastatic spread, cells that have successfully metastasized to secondary sites must overcome both
endogenous mechanisms of control as well as therapeutic interventions. Immune cells are an endogenous
mechanism of control that are often reinvigorated by checkpoint blockade to great therapeutic benefit. One
mechanism by which immune cells control the spread of both primary and metastatic tumors is through the
delivery of cytokines, specifically type II interferons, the production of which is enriched following treatment.
Interferon gamma (IFNγ) has been shown to play a role in both promoting and restricting tumor growth in primary
cancers via overexpression of both MHC-I and PD-L1. However, its role in metastatic disease, particularly
following treatment is less well understood.
This work seeks to clarify the role of IFNγ in metastatic disease. Preliminary data indicates that in the context of
triple negative breast cancer (TNBC) IFNγ signaling restrains tumor growth in the primary site but promotes it in
lung metastasis following treatment. I hypothesize that by studying how IFNγ regulates TNBC’s ability to evade
immune cells and establish metastatic lesions, we can better understand the contexts in which IFNγ delivery by
immune cells promotes or restrains tumor growth in the metastatic setting. To do so, I propose two aims: Aim 1:
Elucidating the role of IFNγ in immune evasion during TNBC dissemination and metastatic growth and Aim 2:
Dissecting IFNγ’ s role in establishing the metastatic potential of primary TNBCs. Combined this body of work
will extend our knowledge of the endogenous role of IFNγ in the antitumor immune response and how modulating
its signaling may play a role in the clinic.
Beyond understanding the roles of IFNγ during metastasis, this proposal also seeks to lay the appropriate training
groundwork necessary for successfully pursuing an independent faculty position. Through a detailed training
plan dedicated to developing both the technical and leadership skills required to successfully lead a laboratory,
this work will be used as a springboard for future applications to tenure track positions. Together with the
research component, this will form a strong foundation for an independent research program dedicated to
understanding how cellular communication effects molecular phenotypes during immune cell interactions with
tumor cells.

Public health relevance
Project Narrative: Interferon gamma signaling has been shown to promote both pro and antitumorigenic phenotypes in primary tumors but its role in metastasis following therapy is little understood. Through mouse models of triple negative breast cancer, we can study the context in which interferon gamma promotes immune mediated tumor growth or control. This work will lead to a better understanding of the endogenous regulation of tumor cells by interferon gamma and how this can be modulated through current immunotherapy regimes.